Cortical circuits for the integration of parallel short-latency auditory pathways

PROJECT SUMMARY
How our brain achieves coherent perception by integrating information from parallel sensory pathways
distributed across space and time remains a central question in neuroscience. In the auditory system, sound
information reaches the cortex via the lemniscal (“primary”) and non-lemniscal (“secondary”) pathways. The
non-lemniscal pathways have often been described as slower integrators of multi-sensory information, in
contrast to the roles of the lemniscal pathways as fast and reliable relays for sound inputs. However, the
contribution of the non-lemniscal pathways in driving fast cortical responses and how they interact with the
lemniscal pathways during sound processing are still matters of debate. Our preliminary electrophysiology
experiments show that layer 6 (L6) of not only the primary but also the secondary auditory cortex receives
sound inputs whose latency can be shorter than the L4 lemniscal inputs. Surprisingly, our retrograde tracing
demonstrates that this short-latency L6 input originates from the non-tonotopic parts of the auditory thalamus,
supporting the role of the non-lemniscal pathway in fast sensory processing. Building on this exciting finding,
we will combine anatomical tracing, in vitro/in vivo electrophysiology, optogenetics, and behavior to delineate
this non-classical pathway and determine how it interacts with the lemniscal pathway to regulate cortical
sensory processing. Specifically, we will examine the hypothesis that short-latency non-lemniscal inputs onto
L6 regulate cortical sound processing in a timing-dependent manner and control the tuning and temporal
fidelity of sound responses. To achieve this goal, this project aims to (1) Delineate the anatomy of the fast non-
lemniscal pathway from the cochlear nucleus to the auditory cortex using both anatomical tracing and in vivo
unit recordings, (2) Determine the synaptic impact of the non-lemniscal input onto cortical cell types by
performing targeted whole-cell recordings in cortical slices while simultaneously activating L6-targeting
thalamic inputs, and (3) Identify the roles of the fast non-lemniscal input in cortical sound processing in vivo by
optogenetically manipulating thalamic inputs onto L6 during unit recordings in the mice performing sound-
guided behaviors. Through our research, we seek to provide a more holistic understanding of auditory
processing across the two major ascending pathways. Since parallel thalamocortical inputs onto L4 and L6 are
conserved across sensory modalities, results from this project will provide insights into the generalizable
principles underlying the cortical circuitry of sensory integration. Ultimately, these studies will help the future
development of targeted treatments for not only hearing disorders but also other sensory integration
dysfunctions.

Public health relevance
PROJECT NARRATIVE Our brains generate a coherent perception of the sensory world by integrating information from parallel sensory channels. This proposed study will delineate parallel auditory pathways that convey different aspects of acoustic information in our brain and elucidate how they converge in the cerebral cortex to generate unified sound representations. Our research will reveal neural circuit mechanisms underlying auditory integration, the knowledge of which could point towards novel targeted treatments for hearing disorders.